3D Bioprinting of feto-maternal barrier tissue models

This project a collaboration with Drs. Ramkumar Menon and Arum Han with a grant awarded from RFA-TR-21-015.

A 3D biofabricated chorio/decidual interface (FMi) tissue model is currently being built in a multi well plate format using well characterized primary choroid trophoblasts and decidua cells derived from healthy pregnancies. The Biofabrication of a layered tissue model of the FMi is being done with a Digital light processing (DLP) 3D printer on a 12-well with two connected sections. The tissue model is assembled by layering chorion trophoblast cells on one side and the maternal decidual cells on the other side. Protocols are being developed by combining cell/ECM/hydrogels as needed, as well as investigating media compositions, and maturation times. FMi Tissues are being validation with immunohistochemistry using markers of cell identity and FMi formation and integrity, electrical resistance measurements, and cell viability.

We are currently developing an inflammatory state that mimics that associated with pre-term birth (PTB) using the biofabricated FMi from SA1. Cells in the biofabricated 3D FMi model are treated with lipopolysaccharide to mimic infection at different time points of tissue maturation and duration. Development of inflammation (disease pathology) will be determined by FMi integrity (immunohistochemistry), immunoassays for markers in media elutes (imbalance of immunohomeostasis), and by microscopy for cytopathology (apoptosis, and necrosis)